The Behavioral Cost of Carbon

PROJECT SUMMARY
The objective of this project is to generate the first empirical estimate of the behavioral cost of carbon – the
human health-related behavioral impacts imposed by incremental increases in greenhouse gas (GHG)
emissions. The societal behavioral costs and benefits of climate stressors caused by GHG emissions remain
unknown in the US and globally. This missing behavioral component of the social cost of carbon (SCC) may
blind both climate and health policy responses to the true scope of consequences from climate change.
This project will evaluate three hypothesized behavioral costs of carbon. This proposal aims to 1) estimate the
first US domestic substance use cost of carbon by linking alcohol consumption observations and substance use
panel data with high resolution meteorological data (i.e. weather and climate observations) across the US; 2)
evaluate the US and global sleep cost of carbon by applying multi-stage multivariate time-series fixed effects
models to estimate associations between local meteorological conditions and both self-reported and
actigraphy-recorded sleep outcomes; 3) assess the preliminary physical activity cost of carbon and estimate
local climate-behavioral impact projections – statistically accounting for acclimatization – for every county in
the US and every region worldwide. In Aim 1, the US substance use cost of carbon will be derived from
estimating climate – substance use response functions for daily household alcohol consumption measured by
the nationally representative Nielsen-IQ Consumer Panel (NIQCP), self-reported individual substance use
registered by the Behavioral Risk Factor Surveillance System (BRFSS), and zip code-level counts of all
substance use disorder emergency department visits (HCUP SEDD) and hospitalizations (HCUP SID) in a
dataset that includes 95% of US hospital discharges. In Aim 2, US and global estimates of the sleep cost of
carbon will be derived from ambient temperature–sleep response estimates using nationally representative US
time use survey data (ATUS) and globally extensive actigraphy data (GSSPAD). In Aim 3, nationally
representative physical activity survey data (BRFSS) and two large-scale wrist actigraphy and
smartphone-based accelerometry datasets from prior research will be linked with global reanalysis (ECMWF
ERA5) meteorological data to estimate climate – physical activity response curves which are then coupled with
climate model output produced by NASA Earth Exchange (NEX) to inform both the US and global physical
activity cost of carbon. This independent research agenda will inform the world's first behavioral cost of carbon
(BCC). The BCC will allow healthcare stakeholders and policymakers to anticipate and mitigate the future
behavioral costs of societal emissions decisions. The proposed research directly responds to the NIH Strategic
Plan's 2021-2025 “disease prevention and health promotion” objective, aligns with the crosscutting themes by
“addressing public health challenges across the lifespan” and “promoting collaborative science,” while also
building cutting-edge spatial data science capacity at the nexus of climate change and behavioral medicine.

Public health relevance
PROJECT NARRATIVE The downstream behavioral impacts of carbon dioxide (CO2) emissions remain unknown in the US and globally, so they are not yet included in the US federal “social cost of carbon,” a metric used to quantify the human damages associated with a one-ton increase in greenhouse gas emissions. This proposed project evaluates the hypothesized behavioral costs of carbon for substance use, sleep outcomes, and physical activity. Characterizing how observed changes in climate, caused by each additional unit of greenhouse gas emissions today, impact future human health behaviors can have major implications for climate and health policies, which currently do not consider the behavioral costs of societies' emissions choices.